Mechanisms of Alzheimers disease pathogenesis in SARS CoV2 infection

PROJECT SUMMARY
This application is a supplement request to our P51 base grant to Tulane National Primate Research Center
(TNPRC) to further the investigation of the Post-Acute Sequelae of SARS-CoV-2 infection (PASC). This
application investigates the overarching hypothesis that SARS-CoV-2-induced dysregulation of metabolic
pathways involved in tryptophan metabolism and upregulation of DNER, a potential marker of ongoing
neurodegeneration, contributes to Alzheimer’s disease (AD) progression. We hypothesize that these alterations
contribute to major pathogenic features of CoVID-19 infection and PASC, particularly neurocognitive
disturbances, which have increased prevalence in persons previously infected with SARS-CoV-2. Alterations in
the Kyn/Tryp levels are known to accelerate AD. Our published studies have shown that systemic Kyn/Typ levels
correlate with the severity of lung pathology in the NHP model of SARS-CoV-2 infection. Our in-vitro studies
demonstrate that spike enhances amyloid beta aggregation and neurotoxicity in hippocampal neurons. The
studies proposed in Aim 1 will utilize samples from ongoing studies on PASC in African Green monkeys (AGMs).
Aim 2 studies will be performed in 5XFAD mice, a well-established AD model, to assess the impact of SARS-
CoV-2 Spike subunit S1 to recapitulate in vitro studies that Spike enhances the acceleration of amyloid beta
aggregation and plaque formation leading to cognitive impairment. This application leverages our ongoing PASC
studies in the African green monkey providing all the necessary samples for this investigation. This application
also takes advantage of the CoVID-19 NHP Coordinating Center at TNPRC, where three other Centers and we
are engaged in Long-CoVID studies and will deposit our data for further analysis. This application represents a
novel inquiry into an exciting hypothesis that may provide new insights into novel and effective therapeutic
strategies for SARS-CoV-2 infection and PASC.

Public health relevance
Project relevance. Covid-19-associated neurological complications are on the rise with a high incidence of symptoms akin to Alzheimer's disease (AD) such as learning and memory deficits. The proposed research is timely and relevant to public health since it will offer novel insight into potential mechanisms mediated by spike protein in fastening AD progression. Findings will allow the development of therapeutic strategies for slowing down AD progression in COVID-19 elderly individuals.